Autonomic Effects of Transcutaneous Spinal Cord Stimulation in Veterans with SCI

Most individuals with spinal cord injury (SCI) retain spared neural activity at and below the site of
injury, activating these neural circuits may enhance neural plasticity to promote recovery of motor,
sensory, and autonomic function. Individuals with SCI struggle with life-long autonomic nervous
system (ANS) dysfunction with serious adverse consequences. The dynamic balance between the
sympathetic and parasympathetic branches of the ANS is impaired in individuals with SCI at or above
T6, which negatively impacts internal homeostasis during daily activities such as transferring from the
supine to the seated position, regulating core body temperature (Tcore), and exercise performance.
For the estimated millions of people living with SCI globally, impaired ANS regulation is common, and
has been implicated in widespread cardiovascular complications, which are a leading cause of
morbidity and mortality in this population. One of the most prominent consequences of cardiovascular
ANS impairment is blood pressure (BP) instability, which includes hypotension, orthostatic
hypotension (OH), and autonomic dysreflexia (AD). These BP impairments lead to an absence or
reversal of the nocturnal BP dip, and increased daytime sleepiness, which detract from
wellbeing, independence, social engagement and quality of life. Further, ANS cardiovascular
impairment in athletes with SCI limits the heart rate (HR) response during competition, lowers BP,
and increases fatigue, thereby compromising endurance and sports performance. In fact, some
athletes with SCI enhance their performance in competition by self-inducing AD, a practice
known as “boosting,” to increase BP and create a generalized efferent sympathetic response.
In addition to cardiovascular complications, ANS deficits post-SCI also contribute to abnormal
sudomotor function and dysregulation of Tcore. With climate change becoming increasingly
apparent, the effects of wide variation in environmental conditions are anticipated to be more
severe and more devastating to overall health, independence, and quality of life in individuals
with SCI who lack adequate ANS thermoregulatory control. For these reasons, individuals with
SCI prioritize restoration of ANS functions higher than regaining the ability to walk; however, there are
no clinical interventions proven to be safe and effective for managing widespread ANS dysfunction
following SCI. This project will focus on using non-invasive, transcutaneous spinal cord stimulation
(TSCS) to restore intrinsic ANS control of BP and determine the effects on exercise endurance and
Tcore. A recent report found that the use of TSCS in 6 individuals with cervical SCI (C3-C5)
improved ANS regulation of HR, sudomotor, thermoregulation, and bladder control and a separate
team found that TSCS restored ANS control of orthostatic BP, cardiac contractility, and cerebral blood
flow velocity in 5 individuals with chronic motor-complete SCI (C5-T2). Most recently, the safety and
efficacy of TSCS was reported during digital anal rectal stimulation (DARS), a known trigger of AD, in
one individual with chronic, motor-complete SCI (C4). The results indicate that TSCS parameters
targeted for BP control restored baseline BP after AD was induced during DARS, and prevented the
BP rise when TSCS was administered before DARS onset. Thus, TSCS does not merely increase
BP, rather targeted stimulation parameters appear to restore intrinsic ANS regulation of BP. Herein,
we propose to test TSCS parameters targeted for BP control (active TSCS) on exercise endurance,
HR recovery from exercise, Tcore responses and subjective reporting of thermal comport during
exposure to a cool ambient environment, in a cohort of participants with chronic SCI, during well
controlled trials compared to a sham TSCS stimulation paradigm.

Public health relevance
Electrical stimulation of the spinal cord aims to take advantage of spared neural circuitry to promote functional recovery following spinal cord injury (SCI). This can be done non-invasively through transcutaneous spinal cord stimulation (TSCS). Small, proof-of-principle studies have shown that TSCS can be targeted to restore blood pressure to more normal and stable levels in hypotensive individuals with chronic, motor-complete SCI. Improved blood pressure control with TSCS is attributed to the restoration of intrinsic autonomic cardiovascular regulation. If true, improvement in other physiological systems that are regulated by the autonomic nervous system should be evident with targeted TSCS. We will identify TSCS parameters that normalize blood pressure in hypotensive individuals with chronic SCI and determine if these TSCS settings improve exercise endurance, recovery from exercise, regulation of core body temperature, and perception of thermal comfort.